Three Rabbit Study: (1) Dose Range Finding Study in Rabbits via Oral Gavage (Non-GLP); (2) Preliminary Embryo Fetal Developmental Study in Rabbits via Oral Gavage (Non-GLP); (3) Embryo Fetal Developme

Three Rabbit Study: (1) Dose Range Finding Study in Rabbits via Oral Gavage (Non-GLP); (2) Preliminary Embryo Fetal Developmental Study in Rabbits via Oral Gavage (Non-GLP); (3) Embryo Fetal Developme